Functions of Rapidly-Evolving Proteins and Their Roles in Pathogenicity

Project Summary
Rapidly evolving proteins constitute a significant portion of a bacterial proteome. These proteins diverge
substantially from their homologs, frequently change functions and locations of active sites, and therefore are
more challenging to study. Fast-evolving proteins are nevertheless as crucial as conserved ones for our
fundamental understanding of molecular evolution and biomedical applications: pathogenicity factors in bacterial
pathogens typically undergo fast evolution due to arms races between hosts and pathogens.
Revolutionary advancements in computational protein science now facilitate the efficient investigation of fast-
evolving proteins. Advanced artificial intelligence methods such as AlphaFold have produced accurate models
of protein 3D structures, which could revolutionize bioinformatics approaches. Now, instead of relying on
sequence-based homology searches, which frequently fail to find relatives of fast-evolving proteins, we can use
similarity in 3D structures, which tend to be more conserved evolutionarily. Additionally, methods for predicting
protein-protein interactions (PPIs) are nearing the accuracy of high-throughput experiments, offering another
approach to gain functional insights to a protein by finding a well-studied interaction partner. The time is ideal to
capitalize on these developments and tackle challenging problems that were previously impossible to address.
In this proposal, I intend to study fast-evolving proteins using state-of-the-art computational methods, followed
by experimental validation. First, I have developed methods to recognize domains from AlphaFold models and
assign them to an evolutionary context for functional inference. I plan to enhance these methods using deep
learning techniques and develop additional methods to predict functional categories. While existing tools are
primarily optimized for conserved protein families with deep sequence alignments and extensive experimental
data, my methods will cater specifically to fast-evolving proteins. Subsequently, I will apply these tools and my
expertise in comparative genomics and PPI modeling to study the fast-evolving and pathogenicity-associated
proteins encoded by the pan-genomes of Vibrio parahaemolyticus (Vpara) strains isolated from human patients.
By determining their evolutionary origins, predicting their interacting partners, and inferring their functions, I aim
to identify a set of uncharacterized and fast-evolving candidate pathogenicity factors (CPFs). Finally, I will select
several promising CPFs and experimentally validate their secretion and interacting partners using medium-
throughput experiments. This preliminary functional characterization will be the initial step toward elucidating the
mechanisms of these novel PFs and will pave the way for future discoveries in my lab and in the field.
This project will allow me to undergo rigorous and multidisciplinary training in cutting-edge computational
methods and experimental techniques that can generate large datasets to complement and validate
computational studies. I expect to contribute to science by sharing my computational tools and analytical results
through a web server and an online database, and by characterizing novel pathogenicity factors in Vpara.

Public health relevance
Project Narrative Leveraging the recent breakthrough in protein structure prediction and progress in the analysis of protein sequences and structures using Artificial Intelligence, I will study the rapidly evolving and pathogenicity-associated proteins encoded by the pan-genomes of Vibrio species that cause vibriosis in humans. This project will establish a framework to combine computational tool development and large-scale data analysis with experimental validation to decipher protein functions, contributing to our understanding of the pathogenicity of bacteria and human diseases.